Role of Cell Type-Specific Molecular Rhythm Disruption in Alcohol Use Disorder

PROJECT SUMMARY/ABSTRACT
Alcohol use is a causal factor in over 200 health conditions and is estimated to account for 5.1% of global burden
of disease and injury. Despite the enormous public health impact, we still lack a basic understanding of the
mechanisms that contribute to alcohol use disorder (AUD). A prominent feature of AUD is circadian rhythm
disturbances, including altered physiological rhythms and sleep/wake cycles. The relationship is bidirectional, as
rhythm disruptions can exacerbate alcohol consumption and polymorphisms in canonical circadian genes
associate with increased alcohol use. However, very little is known about the mechanisms underlying these
relationships, especially at the molecular level in the brains of individuals with AUD. Molecular rhythms are
generated by transcriptional-translational feedback loops to control circadian-dependent (near 24-hour) gene
expression. Notably, AUD is associated with disrupted molecular rhythms of canonical circadian genes in the
periphery and rodent studies have shown that disruptions to molecular rhythms in the striatum, particularly the
nucleus accumbens (NAc), are associated with altered reward regulation and increased risk for substance use.
Measures of molecular rhythms in human postmortem brain, however, have historically been challenging since
each brain represents a single circadian timepoint. An innovative analysis uses “time of death” (TOD) to fit
subjects on a 24-hr ‘clock’; by combining expression data from all subjects, it is possible to reconstruct molecular
rhythm patterns in the human postmortem brain. To investigate AUD-associated molecular rhythm alterations,
we performed a preliminary study examining large-scale transcriptional changes in bulk NAc tissue from subjects
with AUD compared to controls. Notably, core circadian genes (e.g., CRY1, PER2), which display rhythmic
expression in control subjects, were arhythmic in AUD, suggesting a molecular link to behavioral rhythm
alterations observed in AUD patients. However, the NAc is composed of a variety of transcriptionally distinct cell
types with differential roles in alcohol drinking behavior, and the role of molecular rhythms in these cell types has
not been previously investigated. The central hypothesis of this R21 proposal is that molecular rhythms are
disrupted in a cell-type specific manner in the NAc of AUD subjects, and that these disruptions contribute to
excessive drinking. To test this hypothesis, we will use single nucleus RNA-sequencing (snRNA-seq) of human
postmortem NAc tissue to determine how molecular rhythms are altered in heterogenous cell populations in AUD
(Aim 1). We will then manipulate rhythms in specific NAc cell types to determine a causal role for rhythm
disruption in alcohol drinking (Aim 2). Together, these studies will be the first to examine cell type-specific
rhythms in human striatum, how they are altered in AUD, and their contribution to excessive alcohol consumption.
These studies are central to understanding the mechanisms underlying circadian disruptions in AUD and may
result in the discovery of novel therapeutic targets and/or time-dependent strategies for future treatments.

Public health relevance
PROJECT NARRATIVE Sleep and circadian rhythm disturbances are common features of alcohol use disorder (AUD). This proposal will identify molecular rhythm alterations within specific cell types of the human brain in AUD subjects and determine the impact of their disruption in a mouse model of alcohol drinking. A better understanding of the mechanisms underlying circadian disruptions in AUD may result in the discovery of novel therapeutic targets and/or time- dependent strategies for future treatments.